Center for Virtual Care Value and Excellence (ViVE).

Importance: Despite the emergence of virtual care (VC) programs during the COVID-19 pandemic, the sustainability of these programs is unknown because of concerns relating to health access in rural regions, effective integration into clinical workflows, future payment parity, and the misalignment of many of the goals of VC integration with a fee-for-service payment environment. Lack of access to Real-World VC Data and knowledge of the unique needs of different VC stakeholder groups can impede attaining financial sustainability. Similarly, there is no consensus on evidence-based research measurements specific to VC, which hinders the efficiency and sustainability of VC.
Objective: Lay strong foundation for translation research that accelerates the integration and evaluation of VC.
Specific aims: (1) Build and promote a productive coalition of internal and external resources, thought leaders, and stakeholder representatives to enable the use of Real-World virtual care Data and generate innovative and pragmatic approaches to advance scalable integration and value locally and nationally.
(2) Assess the facilitators and barriers for key stakeholders to achieve scalable and sustainable virtual care by conducting semi-structured interviews.
(3) Develop and validate consensus around VC Integration and Value frameworks (e.g., outcome metrics) that will accelerate future translational research and provide evidence-based guidance for VC service and policy.
(4) Train workforce to implement validated VC Integration and Value frameworks to improve human health.
Center Activities: ViVE will continuously grow by learning from conducting its research and supporting the research of others regionally and nationally. To the extent, ViVE will create new infrastructure and provide access to Real-World VC Research Data and VC Expertise that will support and advance VC research. ViVE will assess the facilitators and barriers to achieving cost-effective, impactful, and sustainable VC from key stakeholders using semi-structured interviews. Additionally, ViVE will shift the current status quo of VC research by building consensus around VC Integration and Value frameworks. To ensure the effective implementation of these frameworks, ViVE will conduct workforce training sessions to improve the knowledge and skills required to implement VC frameworks.
Expected outcomes: On successful completion of our research, we expect contributions to include (1) accelerating clinical and translational science NC TraCS (UNC CTSA) by expediting the development of a VC research hub, (2) developing a national VC coalition that advances translational VC research by enabling researchers to access Real-World VC Data, resources, and expertise, (3) building and validating VC measurement approaches and value-based outcomes metrics for Integration and Value, and (4) demonstrating real-world utility of validated outcomes and measurements through implementation in clinical research studies.

Public health relevance
This Center aims to advance the clinical and translational research of virtual care by building a coalition of Real-World Data, experts, and validated frameworks that enable researchers and organizations to ensure valuable, integrated, and sustainable virtual care by supporting implementation science and evaluation.